Diversity Supplement to R35 - Mechanistic Elucidation and Targeted Therapy of Organ Injury and Inflammation following Trauma

Project Summary/Abstract from the Parent Grant (R35 to Matthew Neal): Multiple organ dysfunction
syndrome (MODS) is a leading cause of death after severe trauma, which is a leading cause of mortality
worldwide. MODS is thought to be a consequence of a vicious cascade of excessive inflammation and
coagulation abnormalities but remains incompletely understood. The overarching goal of our research is to
understand how trauma leads to organ injury through inflammation and clotting of blood vessels, or
immunothrombosis. Our research focus is the central role of platelet function in driving immunothrombosis
after trauma. We propose to tackle the following key knowledge gaps in the field:
1) Understand the cellular mechanisms leading to micro-thrombotic organ injury in survivors after trauma
2) Unravel the immune and inflammatory consequences of modern trauma resuscitation
3) Design targeted interventions for post-traumatic organ injury and thrombosis
Project Summary/Abstract for the Diversity Research Supplement: The career development focus of this
diversity research supplement is to foster the continuous effort of inclusion of faculty from under represented
groups by increasing diversity in the Department of Surgery at the University of Pittsburgh and the University
of Pittsburgh Medical Center. Dr. Mota Alvidrez as a Hispanic junior faculty member is a perfect candidate for
this supplement as a very promising physician scientist that brings his expertise to this research team. His
inclusion as a diverse individual will also focus in developing further his expertise in platelet biology/function,
immunothrombosis and endothelial damage using state of the art microfluidic system assessment. Inclusion
of Dr. Mota Alvidrez as faculty in our department aims to foster the success of the project but also by
increasing diversity in faculty appointments particularly by the addition of highly determined and strong-driven
individuals as Dr. Mota Alvidrez. The research supplement aims to develop Dr. Mota Alvidrez independent
research program by growing the mechanisms outlined in the parent grant with his own independent research
development plan. He has an amazing mentoring team with an outlined 5-year plan that will allow ample time
for faculty development, data analysis, mentoring and grantsmanship for him to secure independent funding
to build his research program and laboratory.
The proposed research supplement for Dr. Mota Alvidrez will focus on expanding the scope of the key
challenges in the parent grant outlined above. The scientific scope will add novel hypothesis-driven
experimental studies from the exciting preliminary plan from Dr. Mota Alvidrez to promote the development of
his independent research program focusing in immunothrombosis. Dr. Mota Alvidrez research will fill
knowledge gaps in the field of immunothrombosis in trauma while advancing the needle in post-injury care.
He proposes to study deeper into the endothelial damage post trauma by evidencing platelet receptor
shedding, particularly GPIb, leading to thrombocytopenia. His work will evaluate how dysfunctional platelets
leads to platelet sequestration and microthrombi formation by evaluating the A2 domain in von Willbrand
factor as a key mediator of multimer formation in this process.

Public health relevance
PROJECT NARRATIVE Multiple organ dysfunction (MODS) is a leading cause of death and disability after trauma. The mechanisms promoting MODS after trauma are largely unknown but are believed to involve excessive activation of the immune system as well as the formation of small blood clots in organs such as the lungs and kidneys. This diversity research supplement will expand the scope of the aims of the parent grant by focusing on platelets and their interactions with endothelial cells after trauma. The supplement will support Dr. Mota Alvidrez as a Hispanic Research Assistant Professor in a junior faculty position transitioning to an independent research position in our department. The diversity supplement will promote his independent research by development of the outlined research plans as novel and innovative approach to the parent grant with Dr. Mota Alvidrez's independent research focus in the role of platelets in immunothrombosis development in vascular disease.